Core C- Biostatistics and Data Analysis Core

Core C Project Summary
Core C (Quality Control/Quality Assurance and Statistical Analysis Core) primary focuses on a)
the development, implementation, and validation of “best practices” at all steps of the GCAD
data production activities; and b) the planning and performance of association meta-analyses
combining ADSP and non-ADSP datasets. Specific Aims are: (1) Evaluate variant quality
differences between original and updated calling pipelines; (2) Develop/Extend Quality
Control/Quality Assurance (QC/QA) Pipelines; (3) Quality Assurance of ADES+ADSP
Sequencing Joint Calling and Association Analysis; (4) Quality Assurance of of TOPMed+ADSP
Sequence Joint Calling and Association Analysis; (5) Developing/Extending SV Calling best
practices for ADSP sequencing data.